Astrocyte regulation of cerebral blood flow at the intersection of ischemia and Alzheimer's disease

PROJECT SUMMARY
Astrocytes play a key role in cerebral blood flow (CBF) regulation by modulating cerebrovascular reactivity
(CVR) and neurovascular coupling (NVC). CBF is dysregulated in many neurological disorders, including stroke
and Alzheimer’s disease (AD), and is proposed to contribute to neuronal dysfunction leading to dementia. The
factors that drive CBF dysregulation remain unresolved but are critical to understanding the pathobiology of, and
developing novel interventions for, dementia. We hypothesize that ischemic injuries induce persistent life-long
astrogliosis, with a consequent negative impact on CBF regulation and cognitive performance. Epidemiologically,
a large fraction of AD patients harbor ischemic injuries, and patients who suffer ischemic injuries are more likely
to develop dementia. In pilot studies, we find that mice exposed to a unilateral mild ischemic injury demonstrate
persistent reactive astrogliosis lasting up to 8 months. Further, this chronic time point coincides with impaired
CVR and NVC response in both hemispheres despite the unilateral insult, mimicking observations in patient
populations. CBF dysregulation would produce persistent hypoxia and facilitate Aβ production, which, in turn, can
constrict vessels and worsen hypoxia. As the brain has a high energy demand but few energy stores, this interplay
between CBF dysregulation and Aβ can initiate a vicious escalating cycle of energy crisis. Preliminary data
suggesting that A and ischemia may have additive effects on NVC impairment support this concept. Thus,
ischemia-induced CBF dysregulation could be a triggering catalyst in dementia pathology.
Interactions between ischemic stroke and AD are understudied because of traditional separation of the two
disciplines, confining this relationship to the correlative realm and precluding causality inferences. In this project,
we combine a model of mild ischemia with a transgenic AD mouse model featuring Aβ deposition to
comprehensively interrogate how ischemia-induced CBF dysregulation interacts with Aβ and contributes to
cognitive impairment across life span, with a focus on astrocyte-dependent vasoconstrictive mechanisms. Briefly,
we integrate genetic, physiological, pharmacological, and behavioral strategies to: (Aim 1) chart the progression
of astrogliosis, CVR and NVC impairments, cognitive/behavior deficits, and Aβ pathology across life span at the
intersection of ischemia, Aβ, and aging to unveil temporal causality links; (Aim 2) test the role of 20-HETE, an
astrocyte-derived vasoconstrictive signal, in ischemia-induced CBF dysregulation and cognitive/behavior deficits;
and (Aim 3) determine whether re-expression of metabotropic glutamate receptor 5 in ischemic-induced reactive
astrocytes drives 20-HETE synthesis to impair NVC and CVR. Our findings will reveal novel insights into the
cellular and molecular mechanisms that underlie CBF dysregulation at the intersection of stroke and AD. This
information could be leveraged to design both new biomarkers (CVR/NVC impairment) and therapeutic targets
for early interventions (restoring CVR/NVC) for dementia.

Public health relevance
PROJECT NARRATIVE Blood flow to the brain is very important for healthy neurological function, but it is dysregulated in patients who suffer strokes, Alzheimer’s disease and other related dementias. Here, we will examine whether strokes can initiate disease processes in astrocytes, a key brain cell that controls brain blood vessels, to cause long-lasting decrease in blood flow and contribute to dementia. Findings from this study may guide the development of novel treatment strategies to prevent or reduce dementia by restoring brain blood flow.